Monkey-to-human transfer of trained iBCI decoders through nonlinear alignment of neural population dynamics

Project Summary
Nearly 80% of persons with quadriplegia would consent to brain surgery to regain some use of their hands. Yet,
despite advances made in the past 15 years, Intracortical Brain-Computer Interfaces (iBCIs) remain largely
limited to controlling only the kinematics of simple robotic hand movements. Furthermore, decoder training data
consists of a trajectory the user observes and attempts to imitate, together with the accompanying neural activity.
But this “observation-based” decoding is not feasible for iBCIs that decode force or muscle activity (EMG), signals
which will be needed for more nearly biomimetic iBCIs controlling contact forces and joint stiffness. We now
propose a radical new approach, based on machine learning techniques used in the artificial vison and
image manipulation fields, to “transfer” a decoder computed from data collected from a monkey to a human
with a paralyzed hand. The key to the approach is the observation that the neural activity accompanying
movement lies largely on a low-dimensional manifold within the neural state space of recorded neurons.
The “latent signals” within the manifold bear remarkably stable information about behavior that is potentially
useful for iBCIs. However, any given sample of neurons embeds the manifold in a different coordinate system.
We have previously used Canonical Correlation Analysis (CCA) to realign these manifolds for stereotypic, trial-
based tasks. We used a fixed BCI decoder with CCA-aligned latent-signal inputs to predict arm movement for
as long as two years (“cross-time alignment”). Similarly, we made EMG predictions from a monkey using a
decoder computed for a different monkey (“cross-subject alignment”), and even from M1 signals recorded from
a person with a spinal cord injury (“cross-species alignment”). But CCA can work only on behaviors that can be
trial-aligned, which is not possible for most movements typical of a person's daily life. Here, we propose to
develop a new class of tools based on cycle-GAN, a Generative Adversarial Network. Because cycle-GAN works
by minimizing the distance between point clouds within the manifold, it can be applied to unconstrained
movements. In our initial tests, Cycle-GAN outperformed CCA when used for cross-time alignment of simple
behaviors, but it failed for unconstrained behaviors and cross-subject alignment. We propose to optimize cycle-
GAN by incorporating information about dynamics (Aim 1), and by initially constraining the particular regions of
two partially overlapping manifolds that we subject to the alignment process (Aim 2). We will develop and validate
these methods on data recorded during stereotypical motor behaviors in the lab, on unconstrained data collected
wirelessly from monkeys housed in a large, plastic cage, and from humans with spinal cord injury through an on-
going collaboration with groups at the Universities of Pittsburgh and Chicago. The final result will be a set of
novel analytical tools that can be used both to understand the brain's representation of complex motor behaviors,
and to develop applications to a new class of more broadly applicable iBCIs.

Public health relevance
Project Narrative Nearly 80% of persons with tetraplegia due to spinal cord injury report they would consent to brain surgery to regain some use of their hands, something that can now be achieved in a limited way with a Brain-Computer Interface (BCI). We propose a radically new way to develop BCIs “decoders”, the algorithms that translate brain activity into voluntary movement signals. The final result will be a set of novel analytical tools that can take the plentiful data that can be collected from monkeys and transform it into a BCI decoder that can be used to restore movement to a person with a paralyzed hand.